General Motor Control Mechanisms and Disease Training Program

PROJECT SUMMARY/ABSTRACT
The ability to initiate, execute, and terminate movement effectively is critical for survival but is impaired in a
range of debilitating diseases. Precisely how the nervous system encodes movement and how this neural
machinery is compromised by disease remain poorly understood. A primary mission of the neuroscience
community is to fill these gaps in our knowledge and translate this new information into better clinical
practice. To carry this multi-generational effort forward, it is critical that early career scientists are well-
trained. They need a firm grasp of what we know and don't know, experimental skills at the molecular,
cellular, and systems levels, and dedication to rigorous, quantitative, and ethical research. With these goals
in mind, a group of 30 world-leading basic, clinical and translational motor control scientists have come
together under the directorship of Dr. D. James Surmeier to deliver a training program for pre- and post-
doctoral scientists committed to motor control research at Northwestern University (NU). The goals of the
NU General Motor Control Mechanisms and Disease Training Program (GMCMD-TP) are: 1) to educate
trainees in basic, translational, and clinical motor systems neuroscience at the molecular, cellular, and
systems levels; 2) to provide trainees with the conceptual, technical, and quantitative skillsets necessary to
address major questions, challenge dogma and make impactful research discoveries; 3) to encourage
trainees to consider the disease relevance of their research and its translational potential; 4) to instill in
trainees a deep commitment to rigorous, ethical, and responsible research; 5) to enhance trainees' skills in
communicating their research; 6) to give trainees opportunities to advance their career goals so that we
support the next generation of leaders in the field of motor control. Pre-doctoral trainees in the NU
Interdepartmental Neuroscience (NUIN) program and the Neural Engineering track of the Biomedical
Engineering program, and post-doctoral trainees in the laboratories of program faculty are eligible for the
GMCMD-TP. The GMCMD-TP consists of: 1) a core course covering each aspect of the motor system,
entitled “The Neural Control of Movement”; 2) monthly seminars by preceptors on their motor control
research programs; 3) training and consultation in statistics; 4) an annual retreat where all members of the
NU motor control research community come together to communicate and discuss their research; 5) a
movement disorders journal club for basic scientists and clinicians; 6) opportunities for shadowing
movement disorder clinicians; 7) several annual research center days, each focused on a specific motor
control disease. In addition, GMCMD-TP trainees utilize Individual Development Plans and NU professional
development programs to further promote career advancement. Each year up to 4 pre-doctoral and 3 post-
doctoral trainees will be eligible for direct support for 1-2 years. Trainees in GMCMD-TP labs who do not
receive direct support are offered the same training.

Public health relevance
PROJECT NARRATIVE Precisely how the nervous system controls movement and how diseases with motor symptoms disrupt this neural machinery remain poorly understood. The aim of the Northwestern University General Motor Control Mechanisms and Disease Training Program is to impart to pre- and post-doctoral scientists the skills necessary to move the motor control field forward and, in doing so, advance the careers of its trainees. Through this program, trainees will learn to appreciate the entire motor system, apply modern experimental approaches, pursue major scientific questions in a rigorous, quantitative and ethical manner, and communicate their research discoveries to both fellow scientists and non-scientists alike.